The Regulation of Macropinocytosis

Abstract
This proposal requests funds for the purchase of an IncuCyte SX1 microplate system from
Sartorius, Inc., which will be used to analyze the role of macropinocytosis in amino acid-
dependent growth of macrophages and other cells. The research supported by the parent R35
award has concentrated on the mechanisms and regulation of macropinocytosis in
macrophages. Studies in other research groups determined that increased macropinocytosis in
some cancer cells allows them to grow in nutrient-poor environments by scavenging
extracellular proteins such as albumin. In contrast, our recent collaborative studies of T cells
indicated that free extracellular amino acids necessary for activation of protein synthesis enter T
cells by macropinocytosis. Thus, we hypothesize that macropinocytosis is necessary for the
delivery of extracellular amino acids into cytoplasm and for subsequent increases in cell protein
content. To measure growth in different formulations of media with various concentrations of
leucine and other amino acids, we require the precision, throughput and temporal resolution
offered by the IncuCyte SX1. The instrument is an imaging microplate reader (microscope)
which resides inside a tissue culture incubator. Images of growing cultures of cells are collected
at regular intervals from precise locations in 24- or 96-well dishes. Subsequent image analysis
allows the growth and proliferation of cells to be quantified, such that the time series of each
image field yields plots of cell growth vs. time. We will determine rates of CSF1-dependent cell
growth when leucine concentrations are limiting and at different concentrations of leucine that
support growth. If leucine-dependent growth requires endocytosis, then inhibiting
macropinocytosis and other kinds of endocytosis should shift the concentration curve for
leucine-dependent growth. These studies will define the role of macropinocytosis in the cellular
acquisition of amino acids for growth.

Public health relevance
Narrative This proposal requests funds for the purchase of an IncuCyte SX1 microplate system from Sartorius, Inc., which will be used to analyze the role of macropinocytosis in amino acid- dependent growth of macrophages and other cells. The results of these studies should be relevant to the regulation of growth in normal and neoplastic cells.